Postoperative Neurocognitive Disorder - Strategies for Prevention or Reversal Based on Molecular ad Cellular Mechanisms

PROJECT SUMMARY / ABSTRACT
Aging has long been known to be a risk factor for the development of postoperative neurocognitive disorder
(poNCD), but the mechanisms underlying this observation are largely obscure. Approximately 10% of patients
> 60 years of age undergoing surgery and anesthesia develop poNCD, which can be present for several months.
Work by others indicates that in young adult mice several general anesthetics lead to a redistribution of 5-
containing GABAA receptors (5-GABAARs) into cell surface membranes, which is associated with an
impairment of cognitive function. It has been shown in mice that negative allosteric modulation of 5-GABAARs
blocks the sustained memory-impairing effects of general anesthetics. This is the current “dogma” in the field.
Our hypothesis is, however, that an age-related functional reduction of the 5-GABAA receptor system at least
in part underlies declining cognitive functions with aging. In support of this hypothesis, we have demonstrated
that in aged mice (>18 months of age) both increasing the availability of 5-GABAARs (with chronic intermittent
propofol) and positive allosteric modulation of 5-GABAARs (with MP-III-022) result in cognitive improvements
and an essentially complete block of surgery-induced memory impairments. We now propose to study molecular
and cellular mechanisms underlying age-related cognitive decline including the mechanisms by which increased
activity of 5-GABAARs can attenuate surgery-induced inflammation. We plan to examine the exact timing of
the effects of such an increased functional activity of the 5-GABAARs on blocking the development of
postoperative cognitive deficits to examine differential contributions of a reduction of microglial activation and of
a normalization of an 5 “deficit” with aging. Transcriptomic studies will reveal whether increased availabiliy of
5-GABAARs on cell surface membranes or positive allosteric modulation of 5-GABAARs reverse at least some
of the aging-related changes in gene expression and mitochondrial function. We then want to clarify the role of
a specific GABAA receptor subtype on astroytes and of astrocytes in general on the distrubution of 5-GABAARs
in cellular membranes, in part using calcium imaging in vivo. Finally, we want to identify cellular targets
underlying the prevention or reversal of postoperative cognitive deficits in aged mice. In mice conditionally
lacking 5-GABAARs in different principal neurons and interneuronal cell types and on microglia cells we expect
to see a contribution of 5-GABAARs on multiple cell types to the attenuation of postoperative cognitive deficits.
The involvement of the hippocampus in this process will be assessed by monitoring place cell formation and
stability of the memory engram by calcium imaging in vivo. The proposed studies are envisioned to have a
positive translational impact, providing a pathway for testing the positive modulation of 5-GABAARs in elderly
patients undergoing surgery and anesthesia. Positive allosteric modulators of 5-GABAARs are currently being
developed by others, and once such compounds become available for experimental use in humans, our
proposed studies provide a fundamental science framework supporting clinical studies for poNCD.

Public health relevance
PROJECT NARRATIVE Approximately 10% of the 16 million patients >60 years of age undergoing surgery in the United States annually suffer from postoperative neurocognitive disorder (poNCD), which is associated with increased morbidity and mortality. We propose to study molecular and cellular mechanisms and the involvement of specific neuronal and non-neuronal cell types underlying the development of poNCD in aged individuals, and its reversal by increasing the availability of 5-containing GABAA receptors on cell surface membranes and by positive allosteric modulation of 5-containing GABAA receptors using a multidisciplinary approach involving genetically modified animals, viral transduction approaches, molecular biological, biochemical, transcriptomic and behavioral techniques, as well as calcium imaging of defined neuronal populations in behaving animals. The proposed research is expected to provide fundamental knowledge with translational impact, as when allosteric modulators of 5-containng GABAA receptors, which are currently being developed by others for mild cognitive impairment in Alzheimer’s disease with support of the NIH, become available, clinical trials in humans can be envisioned.